Dynamic Interactions between Intrinsically Disordered Proteins and Curved Membrane Surfaces

Project Summary/Abstract. Intrinsically Disordered Proteins (IDPs) represent approximately 40% of the human
proteome and are implicated in a large number of human diseases, including neurological disorders and cancer.
Therefore, the biological relevance of IDPs has garnered substantial interest over the last decade. IDPs often
interact with curved membranes to form structures that are essential to cellular physiology, such as synaptic and
endocytic vesicles. These interactions are facilitated by membrane curvature sensing. The PI recently discovered
that IDPs are potent sensors of membrane curvature. This discovery is a substantive departure from the
predominant structure-function paradigm, as IDPs lack fixed three-dimensional structure and are often incorrectly
assumed to also lack biophysical functionality. The curvature sensitivity of IDPs, as well as many other types of
proteins, is normally studied at thermodynamic equilibrium. However, membrane-interacting proteins exist in a
dynamic equilibrium between their membrane-bound and membrane-unbound states. It can take minutes to
achieve thermodynamic equilibrium between proteins and membranes, but cellular processes, such as cell
signaling, occur anywhere between milliseconds to seconds. It is clear from this mismatch in timescales that
when thermodynamic equilibrium alone is considered, dynamic information that is pertinent to the timescale of
cellular processes is omitted. Little to no literature exists that examines this phenomenon, likely owing to the
difficulty associated with achieving such experimental measurements. Thus, dynamic interactions between
proteins and curved membrane structures are poorly understood. Using their expertise in quantitative
fluorescence microscopy and protein engineering, the goal of the PI's laboratory is to develop and apply
techniques and strategies that will allow for direct visualization and characterization of dynamic interactions
between IDPs and curved membrane structures. The PI's future research program contains 3 overarching
research projects. Work in Project 1 will evaluate the extent to which protein structure influences adsorption and
desorption kinetics, testing the working hypothesis that curved membranes affect various protein structures
differently. Work in Project 2 will evaluate the impact of protein networks on the binding dynamics of IDPs,
answering questions about the influence of protein multivalency on dynamic behavior. Work in Project 3 will
develop experimental techniques and strategies that mimic the intracellular environment, answering questions
about dynamic interactions between IDPs and curved membrane substrates that occur in the presence of two-
dimensional, phase separated protein mixtures on the membrane surface or three-dimensional protein
aggregates in the bulk solution. As previously mentioned, our current understanding of the interactions between
proteins and curved membranes was derived from systems in which the partitioning of proteins was measured
after thermodynamic equilibrium was achieved. In contrast, the proposed work will fill a key gap in existing
knowledge by directly observing and quantifying dynamic interactions between proteins and curved membranes.

Public health relevance
PROJECT NARRATIVE Membrane curvature sensing is a crucial initiation step for many cellular processes, such as membrane trafficking. Defects in membrane traffic underlie diverse diseases such neurological disorders and cancer, thus making the proposed research relevant to public health. Research on basic biophysical mechanisms involved in membrane traffic is relevant to the part of NIH’s mission that seeks to develop fundamental knowledge that will reduce burdens of human disease.